Host susceptibility to Mycobacterium tuberculosis recurrence in HIV-infected people

PROJECT SUMMARY / ABSTRACT
Candidate. Dr. Kathryn Dupnik is an Infectious Disease-trained physician-scientist committed to translational
research on mycobacterial diseases. She documented the transcriptome profile of the pathologic immune
reactions of leprosy and co-authored 20 peer-reviewed publications on infectious diseases of resource-limited
settings. As an investigator with the TB Research Unit, she established the infrastructure for enrollment and
monitoring of cohorts for study of Mycobacterium tuberculosis infection.
Career Development Plan. Dr. Dupnik’s long-term goal is to become an independent physician-scientist
conducting translational laboratory research on the host immune response to mycobacterial pathogens. Her
short- and long-term objectives are: 1. To gain skills in clinical epidemiology and the conduct of large clinical
cohort studies 2. To gain laboratory expertise in the study of human macrophages and M. tuberculosis 3. To
acquire skills in bioinformatics and statistical analysis of large transcriptional data sets 4. To transition to
independent investigator by preparing a R01 grant and gaining leadership and mentorship skills.
Environment. The proposed research and training will be at Weill Cornell Medical College (New York, NY) and
at GHESKIO centers (Port-au-Prince, Haiti). These institutions have a 35-year history of collaboration to provide
clinical care and conduct patient-oriented research on HIV, which Dr. Dupnik first joined in 2006.
Research. This research is an extension of Dr. Dupnik’s prior work on human immune response to mycobacterial
infection. TB recurrence risk is well-documented in the study population in Haiti. The aims of this grant are
designed to characterize this population at risk and to identify potential patient-oriented therapies.
Specific Aim 1. Characterize macrophages from HIV-infected people with history of at least 2 clinical episodes
of pulmonary TB. We will study macrophages derived from peripheral blood mononuclear cells (PBMC) of 50
HIV-infected people with history of multiple episodes of TB and compare them to 50 HIV-infected people from
the same community who have had one episode of TB without recurrence. The primary hypothesis is that
mycobacterial load in macrophages after in vitro M. tuberculosis infection will be higher in people who had
TB recurrence. We will compare gene expression in the M. tuberculosis-exposed macrophages.
Specific Aim 2. Determine immune correlates for recurrent TB in a prospectively monitored cohort of HIV-
infected patients with TB. We will follow 500 HIV-infected patients with TB for 3 years after TB cure, anticipating
that 40 patients will have a reinfection with a new strain of M. tuberculosis. The primary hypothesis is that whole
blood from these 40 patients will have a transcriptome profile at cure of first TB which is distinct from people who
do not develop recurrent TB, which could be used to target secondary prophylaxis.
Significance. Patient oriented interventions such as antitubercular therapy or host directed therapies could be
implemented once those at highest risk for recurrent TB and the associated mechanisms are identified.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to train Dr. Kathryn Dupnik in the conduct of research on recurrent tuberculosis in HIV-infected people and prepare her for a career as an independent physician scientist focused on translational laboratory research. HIV-infected adults who develop TB once are more susceptible to develop TB a second time, even after successful treatment of their HIV with antiretroviral drugs. Dr. Dupnik will study HIV-infected people with and without recurrent TB to identify immune changes that predict which HIV-infected people are most susceptible to TB, and will improve potential interventions to prevent repeat episodes of TB.